The synergy between radiotherapy and molecularly targete

The goal of this project is to study the interaction of radiotherapy and molecularly targeted agents. This project focuses on expanding drugs that show synergy in vitro to the in vivo setting with the goal of translation to the clinic.